EVALUATION OF A RECOMBINANT INFLUENZA A VIRUS IN HEALTHY ADULTS

To determine the safety in healthy adults of a purified subunit influenza vaccine consisting of uncleaved hemagglutinin expressed in insect cells by a recombinant baculovirus.